Dialectical Behavior Therapy for Justice-Involved Veterans: A Randomized Clinical Trial

Despite substantial efforts to curb Veteran suicide, Veterans continue to die by suicide at
rates that far exceed their civilian peers. To date, substantial resources have been invested into
understanding and treating underlying risk factors and precipitants of Veteran suicide. However,
criminal justice involvement remains an under-examined and under-assessed risk factor for
Veteran suicide. Accumulating research suggests justice-involved Veterans are a high-risk, high-
need population, particularly within the Veterans Health Administration. For example, 11% of
Veteran suicides are precipitated by legal troubles; 79% of Veterans receiving VA supportive
housing assistance have a history of one or more arrests; and 58% of Veterans receiving
outpatient VHA substance use treatment have a history of three or more arrests. Risk for suicide
among justice-involved Veterans is particularly elevated among those with co-occurring
difficulties, such as mental health concerns and/or housing instability. Adequately addressing
Veteran suicide – both for justice-involved Veterans and the broader Veteran population –
therefore likely requires interventions to address the legal and co-occurring difficulties of at-risk
Veterans.
Dialectical Behavior Therapy for Justice-Involved Veterans (DBT-J) is distinctively
designed to address these range of needs faced by justice-involved Veterans, including
heightened suicide risk, antisocial behaviors, mental health and substance use concerns,
community-based structural barriers, and case management difficulties. Combining elements of
three prominent, evidence-based models, DBT-J provides 16 weeks of group psychotherapy,
case management services, and measurement-based care to Veterans with ongoing or recent
criminal justice involvement. Data from two prior clinical trials completed by the proposed study’s
Principal Investigator attest to the feasibility and acceptability of DBT-J within VHA behavioral
health settings. Although preliminary, data also suggest participation in DBT-J may yield
meaningful reductions in risk for future criminal behavior and resolution of high-priority case
management needs. Continued research, however, is needed to further investigate the program’s
efficacy.
Toward these aims, the proposed Phase III clinical trial will:
1) Primary Aims 1-2: Assess the superiority of DBT-J over supportive group therapy in
decreasing risk of future criminal behavior and increasing psychosocial functioning.
2) Secondary Aim: Assess the superiority of DBT-J over supportive group therapy in improving
secondary treatment targets (i.e., suicidal ideation, criminogenic thinking, psychological
distress, substance use, case management needs, quality of life, resilience, suicide-related
behavior, and criminal recidivism).
3) Exploratory Aims 1-2: Assess for differential efficacy of DBT-J across high-priority JIV
subgroups (i.e., violent versus nonviolent most recent offense type, presence/absence of a
substance use disorder, and presence/absence of a severe mental illness); assess long-term
impact of DBT-J participation (versus participation in supportive group therapy) on primary
and secondary treatment targets.

Public health relevance
Dialectical Behavior Therapy for Justice-Involved Veterans (DBT-J) is a comprehensive, integrative program distinctively designed to address the range of mental health, substance use, case management, and legal needs of Veterans with current or ongoing criminal justice involvement. Data from two prior clinical trials attest to the program’s feasibility and acceptability and preliminarily suggest participation in the program may yield meaningful improvements in risk for criminal behavior and resolution of high-priority case management needs. However, continued research is needed to further investigate the program’s efficacy. The proposed Phase III clinical trial aims to investigate the superiority of DBT-J over a supportive group therapy treatment in decreasing risk of future criminal behavior and increasing psychosocial functioning. Secondary and exploratory aims will also investigate superiority of DBT-J in improving secondary treatment targets, potential differential efficacy across special-interest Veteran subgroups, and long-term consequences of program participation.